From Speech Function to Communicative Participation in Dysarthria

PROJECT SUMMARY
Amyotrophic lateral sclerosis (ALS) is a devastating neurodegenerative disease with a prevalence of over 5
cases per 100,000 people. People with ALS (PALS) typically develop bulbar motor symptoms throughout the
course of the disease, often leading to dysarthria, a neuromotor disorder of speech execution. Dysarthria
interferes with successful communicative interactions by reducing intelligibility, increasing the effort required by
listeners to understand the speech signal, and reducing speech naturalness. Gaps in our understanding of the
underlying speech production factors contributing to communicative participation are significant barriers to
identifying treatment targets, identifying the onset of communicative participation restrictions, and monitoring
progress. To address these gaps, a better understanding of the acoustic and perceptual attributes of dysarthria
that degrade communicative participation is critical. The purpose of this project is to identify causal links
between speech acoustic features, perceptual speech features, and communicative participation. In Aim 1, we
test the hypothesis that listener effort and speech naturalness will be strongly associated with communicative
participation using bivariate correlations and multiple linear regression. In Aim 2, we test the hypotheses that
(1) acoustic features related to speech clarity will be strongly associated with listener effort, and (2) that
acoustic features representing prosody will be strongly associated with speech naturalness, using bivariate
correlations and multiple linear regression. In Aim 3, we test the hypothesis that speech acoustics will predict
communicative participation and that this relationship will be primarily mediated through clinical impressions of
listener effort and speech naturalness using a mediation analysis. The long-term goal of the proposed research
is to maximize communicative participation, and thereby improve the quality of life of PALS. Results will inform
treatment by (1) guiding the use of evidence-based clinical tools (e.g., listener effort and naturalness rating
scales) that are associated with communicative participation for assessment and monitoring, and (2) identifying
specific treatment (e.g., articulatory precision, speech prosody) targets to support communicative participation.
This project falls under NIDCD’s Priority Area 3 in Voice, Speech, and Language Research, as it investigates a
causal framework that could support diagnosis, treatment, and progress monitoring in individuals with speech
impairments. Furthermore, this work is in line with NIDCD’s mission to further our knowledge and
understanding of communication disorders.

Public health relevance
PROJECT NARRATIVE Amyotrophic lateral sclerosis (ALS) is a devastating neurodegenerative disease that leads to restrictions to daily communication through quantifiable changes in speech acoustics, intelligibility, and speech naturalness. This project seeks to understand the causal linkages between acoustic speech features, perceptual characteristics associated with clinical impressions (listener effort, speech naturalness), and communicative participation in ALS. Understanding these relationships will inform treatment designed to mitigate restrictions by 1) guiding the development and use of evidence-based clinical tools that are associated with communicative participation for assessment and monitoring, and 2) identify specific treatment (e.g., articulatory precision, speech prosody) targets to support communicative participation.